Role of Cas adaptor proteins during cortical axon pathfinding

SUMMARY
Establishment of proper connections in the developing brain is essential for perception,
language, thought, consciousness, learning and memory. Disruption of any of the
developmental events that participate in circuit formation can result in a range of
neurodevelopmental disorders. Interestingly, signaling by the same guidance cues is used and
re-used at different developmental stages to instruct cell migration, neurite guidance, lamination,
synapse assembly and pruning. During these developmental events neurons encounter multiple
signals at the same time. Does a ligand-receptor pair engage the same downstream signaling
effectors regardless of the particular developmental process? How are multiple signaling cues
integrated within the cell? To begin to answer these fundamental questions we will study the
Cas (Crk associated substrate) family of cytosolic signaling adaptor proteins. Cas proteins are
known to signal downstream of both integrins and axon guidance cues, and are differentially
phosphorylated by these pathways. This makes the study of Cas protein function a unique
opportunity to understand how adhesive and instructive pathways are interpreted and
coordinated inside the neuron during embryonic development. Newly developed tools will probe
deeply into the functional role for Cas proteins during cortical axon guidance and fasciculation.
Given the potential for Cas proteins to act as a nexus where instructive and permissive signaling
pathways converge to regulate cell adhesion, these studies will likely increase our
understanding of circuit development by: 1) exploring a newly discovered requirement for Cas
proteins during cortical development; 2) providing new insight into the poorly understood
crosstalk between adhesion to the substrate and guidance cue signaling during axon
pathfinding in vivo; 3) contributing to our understanding of how disrupted connectivity impacts
cortical processing; 4) providing a platform to assess cortical circuit features underlying normal
local and long-range neocortical communication.

Public health relevance
The central goal of this project is to understand the mechanisms that participate in the guidance and fasciculation of axonal projections in the cortex. These experiments will increase our knowledge about the molecular players involved in this important developmental process, and will also investigate how aberrant pathfinding events affect cortical connectivity at the physiological level.